Understanding the Impact of Influenza A Virus Infection During Pregnancy

PROJECT SUMMARY
A successful pregnancy is associated with an intricate immunological balance that is crucial in supporting the
presence and development of a "foreign" fetus. This balance is marked by physiological changes that can alter
the lung compartment, including the need for increased oxygen consumption, which can influence pregnant
women's response to respiratory infections. For example, influenza A virus (IAV) infection during pregnancy is
more likely to result in severe disease, including hospitalization and even death. During the 2009 pandemic, 29%
of influenza-associated hospital admissions and up to 16% of deaths were in pregnant women. Maternal IAV
infection can also negatively impact the offspring, including increases in spontaneous abortions, fetal death,
small gestational age (SGA), and cognitive dysfunction. Despite these detrimental outcomes, insight into the
underlying mechanisms is still sparse. A fundamental gap in our knowledge is understanding how remodeling of
the lung microenvironment during distinct gestational stages affects the response to IAV infection. A significant
barrier to further these studies has been the difficulty to reliably define gestational dates. To fill this gap in
knowledge, I have employed a robust and reproducible pregnant mouse model whereby I use ultrasound
analysis to more accurately determine the gestational date allowing me to infect pregnant dams at early gestation
(embryonic day (E)8.5), mid-gestation (E10.5) and at the commonly used E12.5 timepoint, which represents late
gestation. My in vivo studies have shown that maternal IAV infection during early gestation is associated with
increased mortality due to lung damage compared to non-pregnant infected mice and mice infected later in
pregnancy, highlighting stage-dependent susceptibility and disease. In pregnant mice infected early in gestation,
I found that there is increased septal thickening and denuded bronchioles suggesting damage to the lung’s
stroma. In collaboration with Dr. Paul Thomas's laboratory, our group recently demonstrated the critical role for
stromal cells in regulating and remodeling the lung microenvironment during response and repair to influenza
(Boyd et al., Nature 2020). Collectively, this leads me to hypothesize that the gestational stage modulates IAV
pathogenesis by altering the lung microenvironment, including marked changes in the lung's stromal cell
populations. I will utilize integrative approaches including histology, flow-cytometry-based assays, single-cell
gene-expression profiling (scEX), and bioinformatics. To address this hypothesis, in Aim 1, I will further assess,
quantify and functionally determine how gestational stage can mediate increased IAV pathogenesis in the
pregnant mother. Aim 2 will further define the impact of gestational influenza infection on maternal lung stromal
cells, a severely understudied area. Upon completion, these studies will have major implications on the critical
gestational window that could be targeted to maximize protection for the mother and fetus from IAV infection,
including restructuring vaccine regimens and therapeutic interventions.

Public health relevance
PROJECT NARRATIVE Maternal influenza A virus (IAV) infection can result in increased disease severity and adverse fetal outcomes. However, surprisingly little is known about gestational stage-dependent susceptibility and disease. I will use ultrasound analysis assess the impact of gestational stage on IAV pathogenesis and further, on the maternal lung stromal cell populations, which are vital in regulating, repairing and remodeling the lung microenvironment in response to IAV infection.